GENERAL SOFTWARE ENHANCEMENTS

The purpose of the contract is to provide software development support to enhance ITAC application portfolio, including rapid development of small-scale applications as well as enhancement of several critical applications utilized across National Heart Lung and Blood Institute (NHLBI and the National Institutes of Health (NIH). The systems include both custom developed software and COTS leveraged platforms. The current systems include but not limited to ePMAP, Grants Dashboard, TRAC, UiPath, SharePoint, Power Platform Applications.